Investigating Alternative Nuclear Reactions for Medical Isotope Production

Investigating Alternative Nuclear Reactions for Medical Isotope Production ABSTRACT The array of radionuclides used for, or considered as good candidates for, nuclear medicine has expanded in recent years. Of these radionuclides 44Sc and 67Cu have shown great promise for use in diagnostic and therapeutic applications, respectively. A challenge associated with translating 44Sc and 67Cu from research scale to long-term medical use is the difficulty in producing each of these radionuclides in large quantities. The production limitation is due to the low cross sections (the probability) of the nuclear reactions that create the purist supply of these isotopes. Since production routes using particle beams commonly used for medical isotopes (protons, neutrons, deuterons) do not result in sufficient cross sections, the proposed work aims to investigate employing heavy ion beam reactions. Heavy ion beams, such as 7Li, offer the potential to produce 67Cu and 44Ti (44Ti is the 44Sc parent) at higher cross sections. The proposed research will focus on the measurement of the cross sections for such reactions. Additionally, post irradiation radiochemistry will be performed so that the final purity of the radionuclides can be compared to the current production methods. Successful demonstration of higher production rates with comparable radionuclide purity will offer an additional production route to make these valuable medical isotopes.

Public health relevance
Project Narrative/Relevence Statement The radionuclides 44Sc and 67Cu are important to the nuclear medicine community for diagnostic and therapeutic cancer applications, respectively. Preventing these radionuclides from transitioning from laboratory studies to full clinical use is the challenge in producing them in large enough quantities to meet the medical need. The proposed research aims to measure nuclear reaction probabilities for alternative pathways to produce 44Ti (the parent radionuclide to 44Sc) and 67Cu to hopefully identify routes to make enough of these important radionuclides to implement their use clinically.